Epigenetic engrams in planarians

ABSTRACT
Although selective synaptic remodeling within neural circuits is widely accepted as the molecular substrate for
storage of memories in the brain—the so called “engram”—evidence exists in different model organisms that
memories and behaviors can be encoded, and possibly transmitted, by RNA, suggesting that acquired neural
states can propagate to molecular species outside the nervous system. There are also rare examples of this
information being inherited through the germline in a transgenerational fashion. Such findings have often been
accompanied by heavy skepticism, arguably because the precise molecular species encoding the memories
have not been identified and the pathways responsible for their biogenesis, movement, and function in the
nervous system are not known.
Here, I propose to utilize the model planarian Schmidtea mediterranea to define the nature of these molecular
memories. Planarians are flatworms with the remarkable ability to regenerate their entire brain after amputation
of the head. A largely forgotten and highly controversial body of work from the 1960’s reported that planarians
could be trained to associate neutral stimuli with punishment and that the effects of training were maintained
after complete brain regeneration. The mechanistic insight of these early studies was limited by the lack of
molecular genetic tools to characterize the phenomenon and precisely manipulate the animals.
In the intervening years, the field of planarian regeneration has experienced a molecular and genomic
renaissance thanks to concerted efforts to develop S. mediterranea as a molecular model system. Many
experimental and genomic tools are now available in this species. I will leverage these tools as well as modern
neuroscience approaches coupled with automated behavioral tracking to uncover the molecular mechanisms
of trans-(re)-generational memory.
Toward this end, we have established new behavioral paradigms in S. mediterranea. Our preliminary data is
consistent with the original observations that associative memories are retained even after decapitation and
complete brain regeneration. We also have extensive expertise in cloning, sequencing, and characterizing the
function of various classes of noncoding RNAs in traditional (mammalian cells) and non-traditional (ant) model
systems and we will deploy this knowledge to identify the RNAs that mediate trans-regenerational memories in
planarians as well as the molecular pathways that regulate their biogenesis, movement, and function.
Trans-regenerational memory recall might share common molecular mechanisms with transgenerational
inheritance of acquired behaviors. Our studies will foster a deeper understanding of neuroepigenetics in
animals with more complex brains, including humans.

Public health relevance
PROJECT NARRATIVE Planarians regenerate their entire brain from scratch after decapitation. We observed that in the model planarian Schmidtea mediterranea, individuals can be trained to associate chemical stimuli with a reward, and that a memory of this training is maintained through decapitation and brain regeneration, consistent with controversial studies from several decades ago. We will utilize modern molecular and genetic to identify the chemical substrate of these trans-(re)-generational memories, with far-reaching implications for neuroscience and epigenetics.